Multicenter, longitudinal study of acromioclavicular joint reconstruction techniques for restoring shoulder complex biomechanics and soft tissue health

PROJECT SUMMARY:
Acromioclavicular joint (ACJ) injuries are one of the most prevalent shoulder injuries among young athletes
participating in contact sports, which could have long-term impacts on shoulder health and function. ACJ
reconstruction surgery is generally recommended for patients with high-grade injuries. Currently, there is limited
evidence supporting the selection of the optimal surgical technique for these patients. Surgical techniques in this
context can be categorized as rigid and non-rigid fixations. Rigid fixations are falling out of favor with sports
medicine doctors due to their inferior outcomes. Therefore, modern ACJ surgical repairs primarily focus on non-
rigid fixations, which can mimic the native anatomy and function of the disrupted joint better. Within non-rigid
anatomical fixation, two sub-categories can be identified. The first, more conventional sub-category is to
reconstruct only the vertical stabilizers of the ACJ (i.e., coracoclavicular ligaments). Lately, reconstructing the
ACJ capsule and the AC ligaments has received increased attention due to their distinct role in the horizontal
stability of ACJ, which is critical to surgical success and better patient outcomes. So, the second sub-category
emerged that combines acromioclavicular and coracoclavicular reconstruction to stabilize the joint more
completely. However, the benefits of this more complex procedure on shoulder mechanics and soft-tissue health
have yet to be determined (Gap 1). Also, within the combined technique, controversy exists on whether to
perform these repairs using suture techniques with bone tunnels (known to increase clavicle/coracoid fracture
risk) or to employ tunnel-free techniques that reduce the complication risks but may be less effective in restoring
shoulder stability and range of motion (Gap 2).
We address these gaps by a multi-center longitudinal study and test three groups of ACJ reconstructed
patients receiving one of the following surgeries: 1) coracoclavicular reconstruction alone with bone tunnels, 2)
combined coracoclavicular and acromioclavicular reconstruction with, and 3) without bone tunnels. We will use
advanced Dynamic Stereo X-ray and cutting-edge Ultrashort Echo Time Magnetic Resonance Imaging to
compare shoulder mechanics and soft-tissue health between cohorts over time. Our central hypothesis is that
shoulder mechanics and soft-tissue health are better restored with the combined acromioclavicular and
coracoclavicular reconstruction. Also, a less invasive tunnel-free combined reconstruction technique provides
similar outcomes to that with bone tunnels. This research contributes significantly to the following areas: 1) the
effectiveness of critical surgical decisions to reconstruct ACJ will be rigorously examined on shoulder mechanics
and soft tissue health over time to identify the gold-standard treatment. Specifically, we will corroborate: a)
whether to concurrently reconstruct acromioclavicular and coracoclavicular structures and b) whether to use the
tunnel-free instead of bone tunnel technique. 2) to identify shortcomings that can be addressed with future
developments, which can vertically advance the treatment of this frequent, potentially debilitating injury.

Public health relevance
PROJECT NARRATIVE: ACJ injuries are quite common among young athletes engaged in contact sports. In cases where the injury is significant and cannot heal by itself, surgical repair is necessary. The focus of this project is to evaluate the efficacy of recent surgical techniques that more completely and less invasively reconstruct the ACJ's soft tissue. The goal is to determine if these techniques can provide optimal shoulder motion, strength, and soft-tissue health over time while minimizing surgical invasiveness. The outcomes of this research will be valuable in identifying the most effective treatment for ACJ injuries, highlighting the limitations of existing techniques, and suggesting ways to improve surgical methods in the future. Ultimately, this will lead to better patient care and recovery after ACJ injury.